Life and Longevity After Cancer (LILAC): The Women's Health Initiative Cancer Survivor Cohort

SUMMARY/ABSTRACT
There are 16 million cancer survivors in the United States, and approximately 60% are age 65 years and over.
By 2040, it is estimated that the number of cancer survivors will grow to 26 million with 73% age 65 and older
and almost 50% age 75 and older. Despite this so-called silver tsunami of older cancer survivors, there are
significant knowledge gaps regarding how cancer and cancer treatment impacts the aging process. There is
also a growing consensus regarding the need for studies of cancer in older adults because of the prevalence of
comorbidities, functional losses, cognitive impairment, and frailty, and particularly for those age ≥ 75 for whom
there are virtually no data. Studies are needed to better understand how cancer and its treatment interact with
underlying vulnerabilities, which in turn impacts the feasibility, safety, and efficacy of interventions in this
population. The Life and Longevity After Cancer (LILAC) project is a cancer survivor cohort embedded within
the Women’s Health Initiative to support studies of cancer survivorship in an aging population. During the initial
funding period, we developed the LILAC cohort of 13,453 WHI cancer survivors who were diagnosed with one
of eight LILAC designated cancers: invasive breast, colorectal, endometrial, melanoma, leukemia, lung,
lymphoma, melanoma, or ovarian. We collected information on first course of treatment, clinical and patient
reported outcomes, as well as archival tissue from 4351 solid tumors. With a minimum of 20 years of data on
these women and a current age-range of 70 to101 years, the LILAC population is poised to provide key
information on cancer and aging to advance our cancer and aging research agenda. To accomplish this we
propose to enhance the LILAC resource through several mechanisms designed to support analyses of
emerging questions. Specifically, we propose: 1) To fill critical gaps in knowledge regarding the self-reported
physical, mental and social health of older female cancer survivors by continuing to enroll newly diagnosed
survivors (N=2685) and follow the LILAC cohort; 2) To develop the analytic framework to assess trajectories of
aging, including an accelerated aging phenotype in the WHI/LILAC database; 3) To establish cohorts of age-
matched WHI participants with similar data who have remained cancer free, to help us understand the
diagnosis of cancer and its treatment on the trajectories of aging, the accelerated aging phenotype and age-
related comorbidities; 4) To obtain performance-based measures of physical function and new post-treatment
blood samples to assess potential biomarkers of accelerated aging; and 5) To maximize the use and impact of
this resource. Given the aging of the US population, the increase in the number of cancer survivors and the
association between cancer and aging, these strategic and timely investments in the LILAC infrastructure will
help to fill many of these critical research gaps.

Public health relevance
PROJECT NARRATIVE To address compelling issues of cancer and aging, we propose to enhance the Life and Longevity After Cancer (LILAC) cohort by continuing to enroll older (70+ year old) cancer survivors from the Women’s Health Initiative (WHI), by establishing measures of frailty, creating age-matched cancer-free controls, and in a subset of participants, conducting a geriatric assessment and collecting a new post-diagnosis blood collection in a subset of participants to assess biomarkers of aging. Further, by making these resources broadly available, LILAC will provide the research infrastructure needed to examine many emerging questions around accelerated aging and resilience in cancer patients.